University of Kentucky Animal Food Regulatory Program Standards Implementation Development and Maintenance, with Mutual Reliance Initiatives

Project Summary/Abstract:
The University of Kentucky Division of Regulatory Services (UKDRS) is committed to
advancing its Animal Feed Regulatory Program in full alignment with the Animal Feed
Regulatory Program Standards (AFRPS). Through this cooperative agreement, UKDRS will
strengthen its regulatory infrastructure and support the goals of the Integrated Food Safety
System (IFSS) in partnership with the U.S. Food and Drug Administration (FDA).
This initiative focuses on four strategic components:
A. Sustaining full AFRPS implementation through continuous quality improvement,
annual reviews, and FDA assessments;
B. Leading and participating in AFRPS-related activities and national collaborations,
including the AAFCO Standards Committee and emergency preparedness
exercises;
C. Applying AFRPS protocols to conduct follow-up inspections, investigations, and
enforcement actions based on robust sampling and compliance frameworks; and
D. Advancing to Phase 3 of the SMG-8076 audit program by training additional auditors
to ensure long-term program sustainability.
UKDRS’s longstanding leadership, technological integration, and commitment to
regulatory excellence, position it as a key contributor to national food safety efforts. This
proposal seeks continued support to enhance program effectiveness, promote mutual
reliance, and protect public and animal health.

Public health relevance
Project Narrative The University of Kentucky Division of Regulatory Services (UKDRS) is fully committed to maintaining and continuously improving its Animal Feed Regulatory Program in alignment with the Animal Feed Regulatory Program Standards (AFRPS). With a long-standing history of collaboration with the U.S. Food and Drug Administration (FDA), UKDRS will continue to strengthen its regulatory infrastructure, promote mutual reliance, and support the goals of the Integrated Food Safety System (IFSS).